ANP Receptor: Genetic and Epigenetic Mechanisms Regulating Blood Pressure and Kidney Injury and Dysfunction

PROJECT SUMMARY
The mechanisms regulating high blood pressure (BP) and kidney injury and dysfunction are known to
have a strong genetic component; however, the specific genes involved in the pathogenesis of hypertension
and renal disorders are not well defined. The key regulators are atrial and brain natriuretic peptides (ANP,
BNP), signaling through natriuretic peptide receptor-A (NPRA) and the second messenger cGMP. There is a
strong association of polymorphisms in the genes that encode ANP (Nppa), BNP (Nppb), and NPRA (Npr1)
with high BP and cardiovascular disorders in humans. It is not clear how the lack of Npr1 in the specific cell-
types of the kidney might progressively lead to high BP and renal disorders, nor what underlies the sex-specific
differences in the disease etiologies. The genetic and epigenetic mechanisms involving transcription factors
(TFs) and modified histone codes, respectively, which regulate the pathogenesis of high BP and kidney injury
and dysfunction are not well understood. The preliminary and published results have provided the intriguing
evidence that retinoic acid receptor-α (RAR-α) agonists enhance the transcription and expression of Npr1 and
receptor signaling; however, angiotensin II (Ang II) and transforming growth factor-beta 1 (TGF-β1) repress
Npr1 transcription and receptor function in primary cultured renal cells. These stimulating and inhibiting
hormones also govern genetic and epigenetic mechanisms of gene expression and regulation by interacting
actions of TFs and histone codes; however, their roles in modulating gene transcription and signaling in
hypertension and kidney disorders are not well understood. The overall objective of the current proposal is to
determine how the hormonal control mechanisms influence the genetic and epigenetic factors that govern the
Npr1 and receptor function, regulating high BP and kidney injury and dysfunction in a sex-specific manner. The
central hypothesis is that Npr1 expression and receptor signaling is reciprocally regulated by genetic and
epigenetic mechanisms, and that the loss of cell-specific Npr1 in nephron tubules and podocytes will trigger
high BP and kidney injury and disorders. The proposed specific aims will test the hypotheses: 1) determine the
mechanisms that repress Npr1 expression and receptor signaling leading to high BP and kidney damage and
disorders, 2) delineate the mechanisms those enhance Npr1 expression and receptor signaling and decrease
high BP and kidney injury and dysfunction, and 3) delineate the interactive mechanisms those impact the
divergent stimulatory and inhibitory factors regulating the paradigm shift in high BP and kidney injury and
dysfunction. The findings of the completed studies should lead to the identification of much-needed new
molecular biomarkers and therapies for the treatment and prevention of high BP and kidney diseases in a
gender-specific manner in humans.

Public health relevance
PROJECT NARRATIVE The present proposal targets unique mechanisms that contribute to the molecular and genetic and epigenetic basis of high blood pressure (BP) and kidney injury and dysfunction. It is anticipated that men and women can have distinct differences in progression of hypertensive kidney diseases; the proposed studies will utilize genetically modified mouse models to provide new insights in developing the therapeutic strategies to appropriately target the treatment and prevention of high BP and kidney injury and disorders. The podocyte and nephron tubule injury and kidney dysfunction can lead to chronic kidney disease and complications that are directly relevant to the mission of NIH/NIDDK.